Proprioceptive Coding of Jaw Movement during Orofacial Behavior

Project Summary
Integration of sensory information with motor commands allows movement to be adaptable. For
example, many survival-critical orofacial behaviors (chewing, drinking, breathing, etc.) involve
updating movement trajectories based on interaction with objects (e.g. matching chewing
patterns to food material properties). Proprioceptors, which are sensory afferents that provide
information about body position, likely play critical roles in this process. However, given that
most past recording of proprioceptors was not performed in awake animals, a clear
understanding of proprioceptor movement coding in the awake context is lacking. This project
will target and record from mouse jaw-innervating proprioceptors (which lie in the hindbrain
mesencephalic trigeminal (MeV) nucleus) during orofacial behavior and test their functional role.
Aim 1 will characterize the functional organization of mouse MeV afferents while developing
genetic tools for targeting this population. Aim 2 will record from MeV neurons in behaving
animals during high-resolution movement tracking. Using this dataset, a systematic quantitative
model will be built for MeV neuron activity during voluntary orofacial behavior. Aim 3 will perturb
MeV neuron activity to understand the functional role of MeV neurons in orofacial
behavior. Completion of this project will involve high-level training in in vivo physiology,
behavioral analysis, and systems/computational techniques. This training will draw upon a rich
environment for neural circuit and systems research, especially based on the expertise in
sensory and motor systems neuroscience in the labs of the Sponsor and Co-Sponsor.
Collectively, the proposed project will define the information coding properties of
proprioceptors during orofacial movement as well as probe the functional role of this information
during behavior. These results could inform strategies for treatment of jaw motor problems seen
in the clinic (i.e. denture-wearing patients, temporomandibular joint disorders, etc.). More
broadly, this work can provide novel insights into the role of proprioceptive information in motor
control, which has wide-ranging implications for the fundamental understanding of movement in
healthy and pathological contexts.

Public health relevance
Project Narrative Movement disorders are a major source of disability. Our ability to treat these disorders is limited by our incomplete knowledge of the neural basis for movement control. This project will study the movement coding of sensory afferents during orofacial behavior, thereby providing key insight into the way that sensory information is used in the control of movement.